Administrative Core

ADMINISTRATIVE CORE: SUMMARY
The Northwestern Brain Tumor SPORE Administrative Core will provide structure and organization to this
program of research, and will function under the direction of Drs. Lesniak (PI) Heimberger (Co-I) and James
(Co-I), with input from the SPORE Executive Committee, and with guidance from the Internal and External
Advisory Boards. The core leaders are accomplished brain tumor researchers, and are experts in tumor
biology, experimental therapeutics, and preclinical as well as clinical studies. As such they are well qualified to
supervise this SPORE, and see to its productivity as well as impact on treatment outcomes for brain tumor
patients. Based on committee and advisory board recommendations, the Core Directors will make final
decisions on any issues that involve the timely progression of the SPORE. Further, as core directors they will
have overall scientific and financial responsibility for this SPORE. They will disburse funds and will receive
regular accounting of the financial status of each project. Staff support for the Core will be provided by Lurie
Cancer Center (LCC) Administrator Dr. Robin Leikin, Grants and Contracts Administrator Mr. Daniel
Rademacher, Program/Advocacy Administrator Ms. Laura Jaros, and patient advocate, Mark Agnew. Through
the efforts of these individuals and activities of the Administrative Core, mechanisms will be in place and
procedures applied for enabling high quality, team-oriented, and productive investigations.

Public health relevance
ADMINISTRATIVE CORE: NARRATIVE SPOREs are multi-faceted and complex research programs with many “moving parts”. The Administrative Core will provide structure and organization to ensure integration and to see that synergy is achieved as a result of interactions between the many parts of this SPORE, and by facilitating Northwestern Brain Tumor SPORE interactions with other NCI-supported programs of research.